Neurotoxicity in the adult rat following chronic exposure to methamphetamine

Pretreatment with methamphetamine (METH) can attenuate toxicity due to acute METH challenges. The majority of previous reports have focused mainly on the effects of the drug on the striatal dopaminergic system. In the present study, we used a regimen that involves gradual increases in METH administration to rats in order to mimic progressively larger doses of the drug used by some human METH addicts. We found that this METH preconditioning was associated with complete protection against dopamine depletion caused by a METH challenge (5 mg/kg x 6 injections given 1 h apart) in the striatum and cortex. In contrast, there was no preconditioning-mediated protection against METH-induced serotonin depletion in the striatum and hippocampus, with some protection being observed in the cortex. There was also no protection against METH-induced norepinephrine (NE) depletion in the hippocampus. These results indicate that, in contrast to the present dogmas, there might be differences in the mechanisms involved in METH toxicity on monoaminergic systems in the rodent brain. Thus, chronic injections of METH might activate programs that protect against dopamine toxicity without influencing drug-induced pathological changes in serotoninergic systems. Further studies will need to evaluate the cellular and molecular bases for these differential responses.
In addition, we have begun to investigate the epigenetic changes that are associated with the chronic use of drugs such as methamphetamine. We have found evidence that histone de-acetylation plays an important role in regulating glutamate receptors in the dorsal striatum.
Rats are undergoing METH SA followed by tests of relapse. We have identified the potential role of potassium channels in abstinence from METH SA. We have also shown that DA receptor antagonism can block METH SA. We have also identified changes in the cannabinoid systems.